Shared Resource Management

SHARED RESOURCE MANAGEMENT (SRM): SUMMARY
Hollings Cancer Center (HCC) supported five shared resources (SRs) in the last cycle and now presents six
SRs, with another one under development. Each SR aims to provide cutting-edge basic, translational, and
population sciences technologies. A distinguishing feature of these SRs is that they are led by highly qualified
scientists who ensure that HCC members have access to state-of-the-art instrumentation, technologies, and
expertise providing high-quality, cost-effective, and rapid service to enhance and enhance HCC members'
research. In addition to experimental design consultation, each SR facilitates the analysis of results for all
services in biostatistics, bioinformatics, genomics, lipid metabolomics, imaging, flow cytometry, and histologic
studies. Shared Resource Management (SRM) is led by the Associate Director (AD) of SR, Steven A.
Rosenzweig, PhD (DCT), in collaboration with the AD of Research Administration (Travis Poole, MHA),
providing scientific and administrative oversight to facilities and personnel. The three HCC research programs
are supported by six established and one developing SR (Social Determinants of Health Shared Resource)
responsive to HCC investigator’s scientific needs. The six established SRs include Biorepository and Tissue
Analysis, Biostatistics, Cell and Molecular Imaging, Flow Cytometry and Cell Sorting, Lipidomics, and the
newly added Translational Science Laboratory. SR leaders and staff are superbly qualified and impart their
enthusiasm and knowledge to all users. In addition to NIH S10 equipment grant applications, additional
institutional funding sources, including semi-annual support from the Provost, have enabled the purchase of
new instrumentation and timely replacement of aging instruments. Additional funds are available through our
successful HCC Equipment and Technology Awards Program designed for SR directors to request
replacement instrumentation and service contracts or through the acquisition of newer, more advanced
equipment. Each respective Internal Advisory Committee annually evaluates the SRs, and recommendations
for SOPs, equipment, and staffing needs are made with input from the External Scientific Advisory Board
(ESAB). New since the last submission, HCC SR is now reviewed annually by the University Cores Committee,
chaired by Rosenzweig. This arrangement harmonizes core management and operations across the
university and ensures that HCC needs are fully addressed. HCC SRs and University Cores were showcased
during the Annual Cores Day program launched in June 2022, featuring oral and poster presentations and
select tours of core facilities. This event was attended by over 120 participants providing evaluations reviewed
by the Cores Committee to prepare for the Cores Day 2023 event. In accordance with the HCC strategic plan,
to power cancer discovery and innovation and train the next generation of investigators, the SRs play an
essential role in moving HCC scientists’ research forward, leading to more high-impact publications, grant
awards, and increased numbers of trainees at all levels since the last submission.